The role of N6-methyladenosine modified RNA in Alzheimer's disease: Equipment Supplement

AWARDED ABSTRACT
The accumulation of oligomeric tau (oTau) is known to drive the pathophysiology of Alzheimer’s disease (AD) and
related disorders. We recently discovered that oTau functions as part of the translational stress response,
forming a complex with methylated RNA (N6-methyl adenosine, m6A) through adapter proteins, such as
HNRNPA2B1, which is itself a risk factor for amyotrophic lateral sclerosis. m6A is known to regulate RNA
degradation and utilization, and the m6A modification is “read” by adapter proteins. This complex accumulates
in stress granules along with other RNA binding proteins (RBPs), many of which are also risk factors for
neurodegenerative diseases. We observe a strong increase of m6A in AD highlights, which the importance
epigenetic transcriptomics in AD. The m6A pathway provides a powerful new path to elucidate mechanisms of
neurodegeneration. The m6A axis also provides an innovative, putative therapeutic target for AD because our
studies using an iPSC-based model of AD show that reducing m6A levels reduces tau pathology and delays
disease progression, suggesting returning m6A to basal levels is beneficial.
Multiple stresses (e.g., β-amyloid (Aβ) aggregation, AD risk genes, vascular dysfunction, inflammation and aging)
converge to drive the pathophysiology of AD. Analyzing stress responses through the lens of RNA metabolism and the
translational stress response provides a vast tool of molecules for elucidating the stress response in AD. Some RBPs,
such as TIA1, HRNPA2B1 and tau appear to be required for responses to synaptic stress, while other RBPs, such as
FUS, appear to respond mostly to genotoxic damage. Many RBPs exhibit genetic changes that are linked to
neurodegenerative diseases, which emphasizes their disease-relevance. The m6A tag links RBPs with RNA
metabolism. Sequencing m6A labeled transcripts provides an additional powerful approach to identify the particular
m6A labeled RNA species respond to stresses and disease. Transcripts showing particularly large disease related
changes in m6A could provide the basis for new disease biomarkers or represent potential targets for disease-modifying
gene therapy. We hypothesize that increases in m6A occur early in disease course in response to tau pathology,
enhance the translational stress response and accelerate neurodegeneration. The studies below will determine which
molecular and pathological changes correlate most closely with m6A levels, and which show the most dynamic
response to m6A reduction. Aim 1 will determine how the m6A transcriptome over the disease course in mouse
models of AD/ADRD, examining both coding and noncoding RNA. Aim 2 will determine how the m6A
transcriptome varies by disease severity and type in human pathological cases. Aim 3 will determine how m6A
contributes to the pathophysiology of tau and neurodegeneration in AD.

Public health relevance
Narrative: This proposal requests the TapeStation 4200, which is a high sensitivity and high throughput of the machine that will allow us to rapidly evaluate human brain samples from patients with Alzheimer’s disease.